Genetic Mechanisms and Evolution

Recent technological advances have transformed genetics research, and social changes have caused major
shifts in best practices for graduate education, research training, and mentoring. We propose an innovative
interdisciplinary predoctoral T32 program, Genetic Mechanisms and Evolution (GME), which is specifically
crafted to meet the challenges and opportunities presented by these changes. The GME program will train a
diverse group of world-class Ph.D. scientists in molecular, statistical, and evolutionary genetics
research who will serve as the next generation of innovative scientific leaders in genetics. Training will
ensure development of multidisciplinary competence across these fields, with a strong foundation in
quantitative and computational analysis for every student.
The GME training program leverages the world-class strength of the University of Chicago in genetics.
Mentors include 56 faculty with extraordinary records of research and graduate training, drawn from 14
departments across the fields of evolutionary, statistical, and molecular genetics. Further, the University’s
unique organizational structure brings all areas of genetics into a single division and makes possible the
interdisciplinary program we propose. Trainees for 18 funded positions will be selectively drawn from 9
graduate programs across disciplinary areas. The pool of potential trainees is extraordinarily well-qualified and
diverse (49% women and 26% URM over the last 5 years).
Trainees will be funded in years 2-3 of their studies, but they will participate in training and advising
activities from matriculation through graduation. A new interdisciplinary core course and breadth requirements
will develop student foundations in molecular, statistical, and evolutionary genetics and build strong skills in
programming and statistics. Specialized workshops and an annual hackathon will provide further rigorous
training in computational and quantitative analysis of modern genetic data. Formal writing instruction along with
workshops in grant-writing and oral presentation skills will train scientists for effective communication and help
ameliorate disparities in preparation among students from diverse backgrounds. Individual development plans,
mentor-mentee contracts, faculty mentor training, and peer mentoring will facilitate trainee success and allow
growth of a mutually supportive community of faculty and students. Participation in a pioneering career
development program will support trainees in finding and preparing for a variety of post-PhD career paths.
Recruitment and retention of an increasingly diverse group of students will be further strengthened by
participating in pipeline and outreach programs, bridge activities for new students, and faculty training to
enhance the inclusivity of the training environment and admissions process. All these activities -- building on
the strengths of an exceptional cadre of trainees, trainers and institutional support – will allow us to recruit and
train the future leaders of 21st century genetics research.

Public health relevance
This interdisciplinary program will train a diverse group of exceptional graduate students to become future leaders in 21st Century genetics research. Students will receive rigorous predoctoral research training from world-leading scientists in quantitative, computational, and experimental approaches to answer fundamental questions in molecular, statistical, and evolutionary genetics. The program will train 90 new Ph.D. scientists in 5 years to make major breakthroughs in understanding how genetic information affects biological systems in health and disease – essential knowledge to better diagnose, prevent, and treat a wide range of genetically-encoded conditions.